Mechanisms of Signaling on Membrane Surfaces

SUMMARY
At the leading edge of a polarized macrophage, a membrane-based chemotaxis pathway directs cell mi-
gration up attractant gradients to sites of infection, inflammation, or tissue damage. Upon arrival, a phagocyto-
sis pathway controls the formation and internalization of a phagosome in which the pathogens or damaged tis-
sue are engulfed and destroyed. Both the chemotaxis and phagocytosis pathways are regulated by PI3K lipid
kinases that serve as regulatory hubs by integrating Ca2+, receptor, G protein, and other input signals while
phosphorylating substrate lipids to produce output lipid signals. The potent lipid signals, in turn, activate multi-
ple downstream protein kinases. In chemotaxis, the lipid signal controls actin and membrane remodeling to
drive the leading edge up the attractant gradient. In phagocytosis, the lipid signal controls processing of the
phagosome including the production of reactive oxygen species (ROS) to inactivate pathogens. Closely related
PI3K pathways regulate other cell processes, notably including cell growth. When dysregulated, PI3K path-
ways trigger or exacerbate a wide array of human diseases ranging from cancer and developmental disorders
to defects in innate immunity, inflammation or autoimmunity.
The two classes of PI3K lipid kinases targeted by this research program are Class 1 PI3-Kinases (PI3K1)
that generate the signaling lipid PIP3 at the leading edge membrane of polarized macrophages, and Class 3
PI3-Kinases (PI3K3, specifically PI3K3 Complex II) that produce PI3P on the surface of the phagosome. The
proposed research seeks to understand the regulation of both pathways by addressing fundamental, broad
questions including: (i) How do PI3K1 and PI3K3 regulatory hubs integrate multiple inputs from Ca2+ channels,
receptors, G proteins and other effectors, and do these inputs combine in additive, synergistic, or opposing
fashions? (ii) How do the resulting PIP3 and PI3P output lipids activate downstream protein kinases, including
some of the most important master kinases in the cell? (iii) How do drugs, potential therapeutics, and disease-
linked mutations inhibit or superactivate key components and reaction steps to generate pathway perturbation
or dysregulation?
To answer these and other questions, the PI's laboratory has developed a unique, two-pronged approach
combining innovative, in vitro single molecule methods with live cell imaging studies. The in vitro studies utilize
single molecule TIRF to elucidate signaling mechanisms in a subsection of the pathway, or signaling module,
that is reconstituted on a supported lipid bilayer under near physiological conditions. The live cell studies em-
ploy fluorescent sensors and cell imaging to test key predictions of the in vitro mechanistic model for relevance
in the cellular context. The PI has a strong track record and continues to play leadership roles in his research
field, as well as the university and scientific communities. Overall, this research program is well positioned to
continue generating fundamental advances with significant impacts on signaling biology and medicine.

Public health relevance
NARRATIVE This research program focuses on lipid signaling pathways controlled by ubiquitous PI3K lipid kinase enzymes. PI3K lipid signaling pathways play central roles in normal macrophage function during innate immunity and, when dysregulated, trigger an array of human diseases. Research is pursuing the molecular mechanisms of regulation in the normal pathway, as well as the mechanisms of dysregulation triggered by disease-linked mu- tations, and the mechanisms by which drugs and potential therapeutics drive pathway activation or inhibition.